Educational Outreach

SPECIFIC AIM 3. To develop and maintain education and outreach programs, and an institutional culture of collaboration and training that fosters the development of systems biologists at multiple career levels. This aim combines the Education and Training Plan and the Outreach and Dissemination Plan.